LAUE DIFFRACTION STUDIES OF INTERMEDIATES OF HEAT SHOCK RELATED PROTEIN, ATPASE

We attempted to study intermediates that may be formed during ATP hydrolysis of the heat shock related protein, ATPase. Crystals of one particular mutant of ATPase was used to perform time-resolved Laue diffraction experiments, in which the rate of hydrolysis is significantly reduced to 100-1000 sec in solution. The data sets were collected at several time increments after ATP was introduced to the crystal via a flow cell. The data were of good quality and completeness, however, the difference maps showed no indication of structural change.